(#6) A novel animal model for determining the role of circadian timing in breast cancer development

Project Summary/Abstract

The increased risk of breast cancer due to working nights or rotating shifts has been attributed to
disruption of circadian rhythms, chronic sleep loss, nighttime light exposure, melatonin suppression, and
chronic stress and fatigue. Because shift work can alter these variables simultaneously, human studies
have been unable to determine the relative contributions of these variables to increased cancer risk.
Several studies in rodent cancer models have purported to show that circadian rhythm disruption
increases cancer progression. Unfortunately, all of the methods used to disrupt rhythms also produce
chronic sleep loss, melatonin suppression, and increased stress hormones, each of which is capable of
promoting tumor growth and proliferation. Therefore, the results of those animal studies cannot be
strictly attributed to circadian disruption. To date, there is not a single animal study that has isolated the
effects of circadian disruption on cancer without these confounds. We believe that a new animal model
is needed to address this problem.
We can eliminate these confounds and directly address the role of the circadian system in tumor
development and progression by employing a new animal model, the circadian-­arrhythmic Siberian
hamster (Phodopus sungorus). This model was developed in our laboratory over the past 20 years and
is uniquely suited for this project because circadian timing can be eliminated without impairing sleep or
inducing stress. Circadian timing is eliminated by a single photic treatment that we have termed, the
Disruptive Phase Shift (DPS) protocol. This protocol eliminates the need to ablate the SCN or alter
gene expression, thus leaving the animals arrhythmic, but neurologically and genetically intact. Thus, we
can directly evaluate the contribution of circadian disruption to tumor development and progression by
completely shutting off circadian timing, and without impairing sleep or inducing stress.
We have chosen to investigate the role of circadian disruption in a breast cancer model where
tumors are induced by the carcinogen N-­methyl-­N-­nitrosurea (NMU;; MNU). This is a widely used and
well-­established model of human breast cancer that works well in our hamsters. NMU is highly specific
for mammary tissue and tumors can be induced by a single injection of the carcinogen. We propose to:
1) definitively establish whether the loss of circadian timing (without impairing sleep) increases tumor
development, 2) determine whether melatonin suppression that accompanies circadian-­arrhythmia
increases tumor development, and 3) use a scheduled feeding paradigm to ameliorate the effects of
circadian arrhythmia on tumor development.

Public health relevance
Project Narrative Dysfunction of the human circadian system is thought to increase breast cancer risk, but human and animal studies have been confounded by concomitant deficits in sleep, which can also increase cancer risk. We propose to employ a new animal model that avoids this problem and in which circadian timing is eliminated in a novel way that leaves animals genetically and neurologically intact. This model will allow us to investigate the mechanisms of circadian disruption that ultimately affect tumor oncogenesis.